RCMI Center for Health Disparities Research

The North Carolina Central University (NCCU) seeks competitive renewal of its RCMI - Center for Health Disparities Research (RCHDR) to continue enhancing NCCU's research ecosystem to develop investigators who are conducting impactful and cutting-edge research to address health disparities (HD). The Center is an interdisciplinary effort at NCCU housed at the Julius L. Chambers Biomedical/Biotechnology Research Institute (BBRI), an institute opened in 1999 to pursue research afflicting populations in NC and to train the research workforce. In this renewal application, a concerted effort was made to establish a robust leadership team for the RCHDR through a group of senior- and mid-level experienced individuals. The Center will be comprised of four Cores: Administrative Core (AC); Research Capacity Core (RCC) (arranged into 5 sub-cores); Investigator Development Core (IDC) and Community Engagement Core (CEC) supporting one basic and one behavioral full biomedical research project plus pilot studies.

Public health relevance
Health disparities in the US have been made worse by infectious disease, thus, increasing its awareness and its need to be addressed. The role of universities and researchers in addressing and being present in the community has proven to be essential to the resolution of these disparities. Through this competitive renewal, NCCU's RCMI Center for Health Disparities Research (RCHDR) will continue enhancing NCCU's research ecosystem to empower scientists conducting impactful and cutting-edge research to address health disparities (HD).